The Role of Inflammation in Regulating Gastric Metaplasia

ABSTRACT
The knowledge gaps this application addresses are how precancerous lesions (i.e. metaplasia) arise and
subsequently fuel adenocarcinoma of the stomach. Infection with Helicobacter pylori (H. pylori) and
autoimmune gastritis both cause chronic inflammation and increase the risk of gastric cancer. This application
includes numerous mouse models and human tissue samples to investigate the importance of immune cells
(mast cells and Th2 T cells) and cytokines (IL4 and IL13) in inducing gastric metaplasia and promoting the
development of gastric metaplasia and tumorigenesis. Identifying inflammatory cells and signals that initiate
metaplasia and drive tumor development could improve the ability to identify individuals at an increased risk of
disease progression, and new immune based strategies to prevent and treat preneoplastic lesions associated
with gastric diseases, including gastric cancer.

Public health relevance
Chronic inflammation in the stomach is associated with gastric diseases, including gastric cancer, a leading cause of cancer related deaths. This proposal is focused on understanding the cellular and molecular mechanisms by which inflammatory cells and cytokines induce gastric metaplasia and its progression to cancer. This knowledge is expected to improve our understanding of inflammation induced metaplasia and inform strategies to diagnose and treat gastric diseases and gastric cancer.